Role of 14-3-3θ in Environmental Toxicant Exposure and Neuroinflammation in Synucleinopathies

Project Summary
The purpose of this NIH F31 application is to obtain support for the PI, W. Jay Stone, for mentored research and
career development activities within his MD/PhD degree training that will strengthen his potential to become a
successful physician scientist. The project goal is to develop skills in neuroscience that will allow the PI to study
key proteins involved in the pathogenesis of synucleinopathies, including Parkinson’s disease (PD) and
Dementia with Lewy Bodies (DLB), using laboratory assays foundational to research in neuroscience. The
primary objective of this research proposal is to investigate the role of 14-3-3θ phosphorylation in the context of
environmental toxicant exposure and the neuroinflammatory response associated with synucleinopathies. Work
from the lab of Dr. Talene Yacoubian, sponsor of the PI, has established 14-3-3θ as a key mediator of pathologic
mechanisms by which neurons degenerate in models of PD and DLB, and serves as a potential target for disease
modifying therapy. Furthermore, our lab has revealed that phosphorylation of 14-3-3θ at serine residue 232
(pS232) modulates its ability to interact with and prevent the aggregation of α-syn, the critical pathologic protein
implicated in PD and DLB. However, the events which lead to aberrant pS232 levels are unclear. This project
aims to increase our understanding of the mechanisms that induce pS232 and promote neurodegeneration in
two synucleinopathy-associated events: exposure to the environmental toxicant, trichloroethylene (Aim 1) and
neuroinflammation (Aim 2). The long-term objective of our research is to better understand the role of 14-3-3θ
phosphorylation within synucleinopathies so that subsequent studies can be devised to target 14-3-3θ for
developing potential disease-modifying therapeutics.
The proposed training plan for Jay Stone is sponsored by his project mentor, Dr. Talene Yacoubian, and co-
sponsored by Dr. David Standaert. The overall goal of the training plan is to provide the PI with a solid foundation
for a successful career as a physician scientist. A project based both in translational approaches, while focused
on a disease-oriented pathogenesis, is the ideal training environment for any aspiring physician scientist.
Included in the training plan are experiences that will help Jay develop in three major areas: 1) rigorous
neuroscience research in synucleinopathies, which includes developing familiarity with the existing literature,
critical evaluation of data, and training in the responsible conduct of research; 2) training in advanced gene
therapeutics, and 3) career and professional development, including grant and manuscript writing, scientific
communications, and the translation of research findings to clinical applications. This proposal drives the
development of skills required to conduct rigorous scientific research in synucleinopathies and advanced
neuroscience skills necessary for the PI’s future career as a neurology physician-scientist focused on precision
medicine and neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE 14-3-3θ phosphorylation at S232 is markedly elevated within insoluble fractions of human brains with synucleinopathy, including Parkinson’s Disease (PD) and Dementia with Lewy Bodies (DLB). We will examine the effect of 14-3-3θ phosphorylation in the pathophysiology of these disorders. Blockade of 14-3-3θ phosphorylation may serve as a potential therapeutic to reduce alpha-synuclein aggregation, neuroinflammation, and neurodegeneration in synucleinopathies.